Developmental origins and homeostatic mechanisms underlying adult phenotypes: multispectral sorting of pigment cells from zebrafish and non-traditional model species

Contact PD/PI: PARICHY, DAVID M
SUMMARY OF SUPPLEMENT REQUEST
The parent project focuses on elucidating mechanisms of pigment cell type and pigment pattern diversiﬁcation
in the ﬁshes of the genus Danio, which includes the zebraﬁsh D. rerio, as well as more distantly related
species. This equipment supplement request seeks purchase of a Cytek Aurora CS ﬂuorescence activated cell
sorter that will greatly enhance our ability to meet the original goals of the award, which require extensive sin-
gle cell RNA-sequencing analyses of pigment cells from wild-type and mutant backgrounds of zebraﬁsh and
other danios, an approach that is proving to be technically intractable and ﬁnancially infeasible with the instru-
ment currently available. The Cytek Aurora CS will also permit us to take an innovative, in vitro approach to
elucidating mechanisms of cell-cell interactions during pattern formation in zebraﬁsh, while uniquely allowing
us to test new hypotheses pertaining to evolutionary diversiﬁcation of cell types using marine ﬁshes (e.g., the
wrasse Cirrhilabrus ﬁnfenmaa) and other species (e.g., rasbora Trigonostigma heteromorpha) that cannot be
bred in the laboratory and that lack the genetic and genomic resources of zebraﬁsh.
1
Project Summary/Abstract Page 6

Public health relevance
Contact PD/PI: PARICHY, DAVID M PROJECT NARRATIVE The proposed research is relevant to public health as it focuses on fundamental aspects of vertebrate devel- opment—including cell-type diversiﬁcation, self-organizing interactions and positional information—that have implications for normal patterning and homeostasis, genetic disease and birth defects, and the goals of replac- ing or repairing lost tissue through regenerative medicine. The specialized equipment requested will greatly enhance the principal investigator's ability to accomplish the work originally proposed, and will allow the use of innovative new approaches, and new model systems, for answering the overarching questions to which the parent award is dedicated. 1 Project Narrative Page 7